Pharmaceutical Research Center

PROJECT SUMMARY / ABSTRACT
The Pharmaceutical Research Center (PRC) operates within the University of Wisconsin Health System (UW
Health); our mission is to ensure that drug research protocols, including those of The University of Wisconsin
Carbone Cancer Center (UWCCC), proceed optimally through established medication use systems and in
accordance with all federal, state, institutional, and sponsor regulations governing clinical research. For each
clinical drug trial, PRC establishes procedure for overall study drug management; develops protocol-specific
workflow; creates drug monograph(s) for health care providers; creates the order set; provides quality assurance
audits; and reviews all protocol amendments. To support the unique needs of UWCCC investigators, PRC
manages gene therapy and hazardous oncology drug trials; provides accurate response to drug interaction
inquiries from investigators; and verifies authorized prescriber status in accordance with NCI requirements.
During the current Cancer Center Support Grant (CCSG) funding cycle, PRC has served 49 unique UWCCC
program members across all six programs, enabled UWCCC investigators to implement 137 peer-reviewed
clinical drug trials and provided study drug oversight for an average of 75 new cancer-focused clinical trials each
year. PRC has also participated in the design process for the research pharmacy to be located within Eastpark
Medical Center, which will house UWCCC clinics. PRC strives to refine, enhance and/or expand our services to
meet the evolving needs of the UWCCC research faculty and our research subjects, while operating in rapidly
changing healthcare and regulatory environments. Our specific aims are to: 1) provide detailed protocol review
and feasibility assessment of each UWCCC drug protocol; 2) ensure all UWCCC study protocols comply with
Good Clinical Practice (GCP) standards; 3) provide services essential to the advancement of clinical cancer
research; and 4) facilitate clinical drug research within UW Health and regional partner locations, and to extend
clinical cancer research across Wisconsin. Strategic initiatives of PRC to be completed within this funding period
include: 1) complete implementation of an electronic investigational drug management system to improve
efficiency, data quality, uniformity, and compliance; 2) implement research pharmacy services at Eastpark
Medical Center to support clinical trials; and 3) complete a gap analysis of our services and quality assurance
program with the NCI Auditing best practice standards. Base funding from the CCSG allows PRC leaders to
serve as members of the UWCCC scientific leadership team to ensure PRC is well positioned to meet the
evolving needs of UWCCC investigators and thereby enhance the ability of our members to enroll patients onto
investigator-initiated clinical studies, in strong alignment with the UWCCC mission to translate new therapies to
clinical application.

Public health relevance
PROJECT NARRATIVE Per PAR-21-321 instructions, this component is not required.